LILRB modulates tumor microenvironment and promotes tumor progression

Project Summary
Myeloid cells, including monocytes and macrophages, are classically activated to clear pathogens and promote
immunity, but these same cells can also be reprogrammed within the tumor microenvironment to become
tumor-associated macrophages (TAMs), where they suppress anti-tumor immunity and promote tumor growth
and metastasis. Studies investigating the biological mechanisms behind anti-tumor “M1-like” classical
maturation versus tumor-promoting “M2-like” alternative activation possess significant therapeutic potential.
Paired Ig-like receptor B (PIR-B), a receptor mainly expressed on myeloid lineages in mice, suppresses
immune activation. The leukocyte immunoglobulin-like receptor subfamily B (LILRB) represents the human
ortholog of mouse PIR-B. We found that PIR-B maintains the M2-like phenotype typical of tumor infiltrating
myeloid cells. Mice deficient in PIR-B have reduced tumor burdens and an infiltrating MDSC profile that
resembles the M1-like classical activation phenotype. Therefore, modulation of LILRB signaling in myeloid cells
may provide a means for controlling tumor invasion/progression. Our group generated a panel of antibodies
against LILRB family members and screened them for functional activity in human monocyte-derived
macrophage cell-based assays. Consistent with our findings in mice, we observed that LILRB antagonistic
antibodies promote classical M1-like activation. Concordantly, macrophages down-regulate M2-associated
lpha while suppressing IL-10 secretion, a profile consistent with M1 classical
maturation. We hypothesize that LILRB is an important homeostatic regulator that suppresses human
monocyte classical activation, thereby playing a key role in tumor progression and metastases. Three specific
aims will be pursued: 1) Modulate the function of myeloid cells through PIRB/LILRB to promote anti-tumor
responses. 2) LILRB controls tumor invasion. 3) Prevent tumor invasion/progression by fostering M1
macrophage differentiation as an immune checkpoint therapy. Studies of the cellular and molecular
mechanisms of action utilized by LILRB are critical for clinical translation. Successful completion of these
studies will lead to a better understanding of how our findings with mouse PIRB can be translated to human
LILRB. Furthermore, LILRB blockade can alter the tumor microenvironment, enhance anti-tumor immunity, and
control tumor cell invasion. These findings may lead to the discovery of novel means by which TAMs/MDSC
can be targeted to combat the immune suppression associated with advanced malignancies. Ablation of
immune suppression and preventing tumor invasion should significantly augment the efficacy of immune-based
therapies for the treatment of advanced metastatic cancer.

Public health relevance
Project Narrative T myeloid-derived suppressor cells (MDSC) are responsible for supporting an environment that promotes cancer progression and invasion. The goal of our project is to understand the mechanism underlying the regulation of Tumor associate macrophage (TAM)/MDSC pro-tumor and tumor invasion by LILRB. The results from this study will be used to design TAM/MDSC-targeted cancer immune therapies.